Racial Bias in Risk Adjustment Algorithms and Implications for Racial Health Disparities: Evidence from Dual-Eligible Medicare/Medicaid Long-term Care Patients in New York

PROJECT SUMMARY/ABSTRACT
A growing body of evidence demonstrates the presence of racial bias in data algorithms. In healthcare, racial
bias could arise due to systematic biases in classification and coding, data availability, or data accuracies that
differ across racial groups. For instance, algorithms that use data on healthcare costs—rather than illness—to
predict need tend to allocate too few resources to Black patients who are underserved by our current system
and generate lower spending than white patients with the same health conditions. This issue is increasingly
relevant because most U.S. public health insurance programs operate capitated managed care systems, in
which beneficiaries enroll in private insurance plans, and the government pays insurers a fixed monthly
capitation payment per enrollee. These per-capita payments are typically calculated using risk-adjustment
algorithms, in which patient costs are predicted with information on age, gender, and selected health conditions
from data on past enrollees. However, race is often excluded from these algorithms, raising the possibility that
risk-adjusted managed care could widen racial disparities in care and outcomes among patients. Yet there is
little empirical evidence on the impacts of risk-adjusted managed care systems on racial differences in care
and health outcomes, especially in high-cost settings, such as long-term care. This project will advance
knowledge on these issues by studying the causal effects of risk-adjusted managed long-term care (MLTC) on
racial disparities in care and outcomes among dual-eligible Medicare/Medicaid long-term care beneficiaries in
New York, using 8 years of administrative data on Medicaid and Medicare enrollment, claims, and assessment
records. The project will identify the effects of risk-adjusted MLTC on a range of care utilization and health
outcomes, including inpatient, post-acute, nursing home, and at-home care, prescription drug use, and
mortality, separately by patient race/ethnicity. Leveraging the county-by-county rollout of managed care
mandates, the analysis will use difference-in-differences models to compare within-county changes in
outcomes of patients in New York from before to after managed care was implemented. We will estimate
separate models by race/ethnicity of the patient, testing for statistical differences in MLTC effects. The project
will also identify subgroups who are most severely affected by racial bias in risk-adjustment algorithms, through
sub-group analyses that compare effects by gender, age, presence of chronic conditions, and zip code level
median income. The project will additionally examine the role of managed care plan features in driving racial
disparities in health care utilization and health outcomes. Results will help policymakers, healthcare
organizations, providers, and patients to understand the implications of bias in risk-adjustment algorithms on
patient health, identify subgroups of patients who are most severely impacted, and learn about effective plan
features that could curb or eliminate racial health disparities in managed care settings.

Public health relevance
PROJECT NARRATIVE – RELEVANCE While a growing body of evidence demonstrates the presence of racial bias in algorithms, little is known about how racial bias in algorithms impacts disparities in public health insurance programs, such as Medicaid and Medicare. The central objectives of this project are to: (i) obtain causal estimates of the effect of risk-adjusted managed long-term care (MLTC) on different care utilization and health outcomes among dual-eligible beneficiaries in New York, separately by patient race/ethnicity; (ii) identify differences in the magnitudes of racially disparate impacts across other patient characteristics, including sex, age, health status, and local area; and (iii) identify differences in the magnitudes of racially disparate impacts across different types of plans. This research will help policymakers, healthcare organizations, providers, and patients understand how bias in risk- adjusted MLTC impacts patient health, identify the subgroups of patients most severely impacted, and learn about the plan features that contribute to curbing or eliminating racial health disparities in managed care.